Development of optimized adeno-associated viral capsids for muscle gene therapy

PROJECT SUMMARY. Gene therapeutics offer hope to many patients with rare muscle and neuromuscular
diseases. Despite some early successes, several serious off-target safety concerns have compromised their
development due to hepatic toxicities and related immune responses to the adeno-associated viral (AAV)
vectors. The generation of novel capsids with superior muscle specificity could, therefore, revolutionize the
muscle gene therapy space by avoiding the off-target effects that compromise drug efficacy and safety. Our
objective is to engineer novel AAV capsids with muscle tropism that exceeds the current “muscle tropic”
serotypes (e.g. AAV6, AAV8, AAV9, AAVrh74 & MyoAAVs) as none is actually “muscle-specific”. Indeed, all of
these serotypes can transduce other tissues, especially the liver, which is functionally linked to the noted clinical
toxicities. In fact, the liver functions as a sink for these vectors, limiting muscle transduction and elevating the
minimally effective dose. We hypothesize that de-targeting the liver while simultaneously enhancing muscle
tropism is key to improving muscle gene therapy safety and efficacy. Other groups have sought to enhance
muscle tropism using directed evolution. This high throughput method artificially selects capsids with improved
muscle tropism, but cannot also de-target the liver. By contrast, we will use a rational design approach to
simultaneously target known epitopes for liver de-targeting, enhanced AAV-receptor binding and improved
muscle targeting. These include those for improved sialic acid/AAV-receptor binding, impaired liver
targeting/heparin sulfate binding, improved integrin binding and capsids with combined properties. We will also
use AAV6 as liver- and muscle-targeting epitopes are known for this serotype, but not for the other serotypes.
Milestone 1 will develop liver de-targeted/muscle targeted AAV6 capsids using well-established in vivo and in
vitro imaging approaches. Milestone 2 will demonstrate functional efficacy by comparing a Smad7 muscle gene
therapeutic featuring a wild-type AAV6 (AVGN7) to one with a novel optimized AAV6 capsid. These studies are
understandably high risk yet their significance is disproportionately much higher as they will create a liver de-
targeted capsid with improved muscle tropism and as a result, vastly superior safety and efficacy profiles. This
would substantially innovate the muscle gene therapy space primarily by reducing a manufacturing burden that
limits drug use to younger or fewer patients and thus, reducing the overall treatment costs while expanding the
number of potential patient therapies.

Public health relevance
RELEVANCE TO PUBLIC HEALTH. The loss of striated muscle mass and function in patients with a rare neuromuscular disease significantly compromises quality of life and is often fatal. The proposed studies will develop novel adeno-associated viral capsids for improving the efficacy and safety of muscle-focused gene therapeutics. Ultimately, these capsids will be incorporated into a gene therapy program for inclusion body myositis and Duchenne muscular dystrophy and will be licensed to other commercial programs targeting these and other neuromuscular disease indications.